Proteomic Profiling of Cardiac Dysfunction in the MACS-WIHS Combined Cohort Study."

Abstract
Fund Year 2023 OAR Strategic Funds are requested to perform high-throughput proteomic
measurements to investigate the protein signatures of cardiac dysfunction and its progression in
MWCCS. Previously collected blood specimens in participants who completed baseline
echocardiography in MACS Visits 67-71 (n=1195) and WIHS Visits 44-50 (n=1655) will be used
to measure proteomics in order to permit discovery of protein markers. Genotypic data in MACS
and WIHS will be leveraged to conduct Mendelian randomization analysis using protein
quantitative trait loci, allowing causal inference and selection of protein targets for
pharmacotherapy. This supplement will support HIV/AIDS research corresponding to the
following NIH high-priority AIDS-designated topics: (1) HIV-associated comorbidities; (2) cross-
cutting areas involving clinical translational research, cardiovascular disease, proteomics, multi-
omics, and health disparities; and (3) training of the next generation of HIV investigators in
omics and comorbidities research.

Public health relevance
Project Narrative People living with HIV and those at risk for HIV have high rates of heart disease, but the reasons for this are not fully understood. We plan to measure thousands of proteins in blood from study participants with and without HIV to study their relationship to abnormal heart function measured by ultrasound. By also using information from participants' genes, we may identify new causes of heart disease that could lead to better treatments for people with and without HIV.